Influence of NOX4 activity on muscle fibrosis after spinal cord injury

Skeletal muscle fibrosis is a pathologic consequence of spinal cord injury (SCI) for which no effective treatment
options exist. SCI-induced muscle fibrosis hinders physical rehabilitation efforts by worsening muscle force
production, impairing muscle regeneration, and promoting contractures, which contributes to limb impairment
caused by SCI. The lack of treatments to counter muscle fibrosis after SCI is largely due to a major knowledge
gap in understanding the cellular and molecular pathway(s) underlying its development. Nicotinamide adenine
dinucleotide phosphatase [NAD(P)H] oxidase 4 (NOX4) is a reactive oxygen species (ROS) generating
enzyme that is an anti-fibrotic target in several tissues, including heart, kidney, liver, lungs. Recently, Hammers
(Co-I) identified NOX4 as a driver of muscle fibrosis associated with muscular dystrophy and utilized genetic
NOX4 inhibition (NOX4i) and pharmacologic NOX4i (via GKT831) to substantially reduce myofibroblasts in
dystrophic muscle and to effectively reverse muscle fibrosis and improve muscle function. The goal of this
proposal is to investigate the therapeutic potential of NOX4i in SCI-induced muscle fibrosis. We have
established a rat SCI model that exhibits permanent hindlimb impairment and reproduces the skeletal muscle
phenotype of persons with severe SCI on a timescale that facilitates ‘high-throughput’ testing of potential
interventions. As evidence, muscle fibrosis and atrophy develop over many months in persons with SCI, while
our SCI model exhibits peak fibrosis and atrophy rates within 1-2 wks. A causative role of NOX4 in promoting
SCI-induced muscle fibrosis has yet to be explored. Although, compelling preliminary data indicate that 1)
expression of the Nox4 and other genes associated with fibroblast activity, ECM deposition, and collagen
crosslinking are significantly elevated in muscle during the rapid fibrogenic stage in SCI-affected muscle (RNA-
seq data from Co-Is Barton & Yarrow) and 2) NOX4 protein is persistently localized to fibrotic areas in muscle
after SCI. These data support the central premise of this proposal: heightened NOX4 promotes SCI-induced
muscle fibrosis. For this project, rats will undergo Sham surgery vs severe SCI. SCI rats will receive vehicle
vs GKT831, a small molecule NOX1/4 inhibitor, using immediate and delayed treatment strategies to discern
preventative vs restorative efficacy. Studies will: 1a) identify the GKT831 dose that best attenuates NOX4
activity and fibrosis, 1b) assess the degree to which NOX4 activity and muscle fibrosis change after
discontinuing GKT831, and 1c) determine the magnitude of fibrosis reversal and muscle recovery when
GKT831 is delayed until fibrosis is established. Rehabilitation-centric outcomes and mechanistic outcomes will
be assessed to maximize the potential for future translation and to advance the understanding of SCI-induced
muscle fibrosis. This approach is innovative because it targets NOX4, which is upregulated after SCI and
associated with muscle fibrosis, using a safe and orally available drug that alleviates fibrosis in dystrophic
muscle and other organs. This is a high-risk, high-impact proposal because it is unknown whether NOX4
activity underlies SCI-induced muscle fibrosis or if NOX4i is sufficient to reduce fibrosis and improve muscle
function. Regardless, this project will determine the therapeutic impact of NOX4i on SCI-induced muscle
fibrosis and, if successful, will support the advancement of NOX4i to clinical trials for SCI patients, which may
be transformative for both Veterans and non-Veterans with SCI. There are two Specific Aims.
Aim 1: Determine the ability of NOX4 inhibition to prevent and/or reverse muscle fibrosis and promote
muscle recovery in a rat severe SCI model.
Aim 2: Assess the magnitude to which NOX4 inhibition alters downstream cellular and molecular changes
associated with fibrotic infiltration of muscle after SCI.

Public health relevance
More than 42,000 persons with spinal cord injury (SCI) are eligible for treatment in the VA Healthcare System, with direct healthcare expenditures exceeding $716 million/year. Skeletal muscle fibrosis is a pathologic and currently unresolvable consequence of SCI. Fibrosis worsens muscle force producing capacity and promotes contractures, thereby facilitating limb impairment and hindering physical rehabilitation efforts. There is no known treatment for SCI-induced muscle fibrosis because a major gap exists in understanding of the cellular and molecular signals that stimulate fibrosis after SCI. As such, significant need exists to identify these signals and to test therapeutic strategies that target muscle fibrosis in the impaired limbs after SCI.